The Interaction of Public Health Emergencies: Understanding Nation-wide and City-wide Spatiotemporal Dynamics of COVID-19 Transmission in a Warming World

Program Summary
I am an early-stage investigator and recent KL2 scholar who has used econometric and spatiotemporal meth-
ods to examine the propagation of C-19 in vulnerable populations. The focus of this R03 is to build on this work
to examine the interaction between two devastating public health emergencies: the COVID-19 (C-19) pan-
demic and climate change-amplified extreme heat events (EHEs). Although coronaviruses in general survive
longer in environments of lower humidity, temperature, and sunlight, C-19 propagation has surged in summer
months. A proposed explanation is that SARS-COV2 remains stable in hotter, humid environments, and that C-
19 transmission is promoted by heat-avoidant behavior that increases indoor physical proximity and air condi-
tioner use. EHEs adversely affected one in five Americans. Thus, EHEs may intensify C-19 propagation, partic-
ularly among more individuals and subpopulations vulnerable to both C-19-related and EHE-related morbidity
and mortality – older aged individuals with medical comorbidities, socioeconomically disadvantaged individu-
als, and minorities. An examination of this interaction will provide the first evidence of the association between
climate-amplified EHEs and C-19, providing important data for future pandemic preparedness and climate-am-
plified infectious disease propagation – a critical area of inquiry as described by several institutions, including
the Federal Government. This proposal’s central objective is to examine the relationship between EHEs and C-
19 propagation, providing data that can subsequently be translated into future tools for pandemic prepared-
ness in the age of climate change. My central hypothesis is that EHEs increase C-19 risk by increasing house-
bound populations and promoting SARS-COV2 transmission dynamics, particularly in areas with higher pro-
portions of older aged individuals, racial/ethnic minorities, and other socioeconomically disadvantaged individu-
als. I will test this hypothesis by employing multivariable spatiotemporal models with quasi-experimental de-
signs on several secondary data sources from the Johns Hopkins Coronavirus Resource Center (daily, nation-
wide, county-level C-19 outcomes) and patient-level data from the NCATS National COVID Cohort Collabora-
tive (N3C), combined with area-level socioeconomic data from the US census, and environmental data from
the National Weather Service (NWS) from 2020-2022. The aims are: 1) To examine the association between
EHEs and county-wide C-19 risk from a national perspective; and 2) Identify adult individual-level demo-
graphic, clinical, and area-level socioeconomic characteristics associated with increased risk of C-19 related
hospitalization after EHEs. This work is highly relevant to the National Institutes of Health (NIH) Strategic
Framework for Climate Change and Health Initiative. In addition to supporting my pathway to independence as
a translational physician-scientist, findings from this proposal will lay the foundations of future work focused on
infectious disease epidemiology and climate change in a future R01 submission to the NIEHS or NIAID.
1

Public health relevance
PUBLIC HEALTH STATEMENT Extreme heat events (EHEs) may intensify COVID-19 (C-19) propagation, representing the interaction of two devastating public health emergencies: the C-19 pandemic and climate change. This proposal will provide the first rigorous evidence of the association between EHEs and C-19 propagation using a quasi-experimental de- sign, as well as identifying individual and other factors increasing risk of C-19-related morbidity during EHEs. Findings will provide an important first step to overcome roadblocks that currently limit tailored public health risk messaging and interventions for individuals vulnerable to C-19-related and extreme heat event-related morbidity and mortality as these two public health emergencies interact. 1